Transforming Research and Clinical Knowledge in Older Veterans with Acute Traumatic Brain Injury (TRACK-VA)

Acute traumatic brain injury (TBI) in older veterans is an under-recognized public health emergency for
Veterans Health Administration (VHA). The highest and fastest rising incidence of TBI in the U.S. is in older
adults, mostly due to ground-level falls. Compared with younger patients, older adults with TBI have higher
mortality, lower rates of functional recovery, and may be at especially high risk for post-TBI dementia. Details
of clinical and biological characteristics of older Veterans with acute TBI are incomplete, and insufficient to
implement evidence-based practice guidelines or plan clinical trials. However, pre-existing TBI,
medical/psychiatric conditions, and substance use – common in older Veterans – are emerging risk factors for
sustaining TBI and for worse outcomes after TBI. There is an urgent need to comprehensively characterize
acute TBI in older Veterans presenting to VA hospitals to inform effective interventions to optimize outcomes.
Barriers to progress are: 1) Older adults, especially older Veterans, are underrepresented in acute TBI
research. The 18-site NINDS-funded Transforming Research and Clinical Knowledge in TBI study (TRACK-
TBI; U01NS086090) had no VA sites and, per protocol, excluded older adults with pre-existing conditions; (2)
Emerging TBI blood-based and neuroimaging biomarkers have not been validated in older Veterans, many
with pre-existing conditions and military relevant exposures that may reduce accuracy. To begin to address
age-related barriers to progress, we received funding from NIH for the Transforming Research and Clinical
Knowledge in Geriatric TBI (TRACK-GERI; R01 NS110944 2019-2024) study, a 5-year 2-site TRACK-TBI
Network prospective cohort of acute geriatric TBI in patients presenting to Level 1 trauma centers. However,
this study will not capture patients who present to VAs or non-trauma center Emergency Departments (ED).
Thus, TRACK-GERI will not elucidate the unique features of geriatric TBI in Veterans presenting with mostly
mild TBI to VA EDs. To fill this gap, we propose to leverage the existing TRACK-TBI Network data and
expertise of our exceptional multi-disciplinary team at SFVA/UCSF to achieve these scientific aims: Aim 1:
Characterize baseline and 12-mo longitudinal clinical features using TBI Common Data Elements (CDEs)
among Veterans age ≥65y enrolled in the TRACK-TBI and TRACK-GERI studies with acute TBI. We will
analyze existing data collected at TRACK-TBI’s 18 non-VA Level 1 trauma centers and explore comparisons to
civilians (existing geriatric cohort data consists of N>60 Veterans, N>250 civilians).Aim 2: Assemble a new
prospective cohort of Veterans age ≥65y presenting to SFVA ED ≤72h after TBI who received CT (“TRACK-
VA”) and deeply phenotype clinical and biological features over 12-months using TBI CDEs. Enroll 70 TBI
patient/study-partner dyads and 30 matched ED controls (with medical/orthopedic conditions discharged from
the ED), perform baseline clinical assessments (pre-injury health, MREs), blood draws (for APOE, proteomic
analysis), brain MRI, and assess longitudinal outcomes at 2wk, 3mo, 6mo, and 12mo post-injury. Aim 3:
Characterize neuroimaging features of acute geriatric TBI in Veterans using TBI CDEs and quantitative
structural and functional MRI. Obtain structural (T1, T2, susceptibility weighted imaging, multi-shell diffusion
imaging, diffusion tensor imaging, neurite orientation dispersion and density imaging) and resting-state
functional MRI at 2-wks, 6-mo, and 12-mo post-injury in a sub-set of the TRACK-VA cohort (N=50 TBI; N=25
controls). Characterize acute intracranial trauma on 2-week MRI and characterize longitudinal structural and
functional changes. Aim 4: Determine accuracy of blood-based GFAP, P-tau, Abeta, and NFL for TBI
diagnosis, prognosis of outcome, and disease-monitoring in older Veterans. We will obtain blood at £72h, 6mo,
and 12mo post-injury. This project will comprehensively characterize baseline and longitudinal
endophenotypes of an intentionally heterogeneous, “real-world,” population of older Veterans presenting with
acute TBI. Findings will inform development of effective interventions to optimize outcomes.

Public health relevance
This project will focus on two VA Clinical Science Research and Development priority research areas: (1) traumatic brain injury (TBI) diagnosis and (2) diseases with a high healthcare burden in Veterans. Over the 4- year timeline of this project, it is expected that the total number of acute TBIs sustained by older Veterans residing in the U.S. (N>520,000) will exceed the total number of TBIs sustained by active duty service members in the past 20 years (N=413,858). Geriatric TBI is a massive epidemic within Veterans Health Administration (VHA) with high associated morbidity, mortality, and cost. Yet, acute geriatric TBI has never been prospectively studied by VHA. This pioneering project will comprehensively characterize baseline and longitudinal endophenotypes of older Veterans presenting with acute TBI to our VA. Findings will inform precision medicine approaches to age-appropriate diagnosis, treatment, and disease-monitoring that are urgently needed to improve outcomes in this large and burdened population of Veterans.